MECHANICAL ACTIVITY, NITRIC OXIDE, CARTILAGE HEALTH

DESCRIPTION (Adapted from the Applicant's Abstract): The TMJ is a synovial joint subject to destruction from inflammatory diseases such as arthritis. The arthritic diseases involve cytokines and are associated with cartilage matrix degeneration. The exact mechanism for this degeneration is unknown but has been shown to involve the effector molecule nitric oxide. Nitric oxide has been shown to be markedly increased in chondrocytes in response to cytokine stimulation and this increase leads to inhibition of chondrocytes matrix biosynthesis. Continuous passive motion therapies yield beneficial effects on arthritic and inflamed synovial joints and are likely to involve mechanical activation using the Flexcell system markedly decreases production of nitric oxide in chondrocytes. Preliminary data indicate that mechanical activation using the Flexcell system markedly decreases production of nitric oxide in chondrocytes stimulated by inflammatory mediators. The applicant hypothesizes that this inhibition is due to a decrease in inducible nitric oxide synthases. This inhibition will led to improved matrix synthesis by chondrocytes. He proposes to determine if the inhibition of nitric oxide production in chondrocytes is a result of a decrease in inducible nitric oxide synthases and if matrix production is improved as a result of the inhibition of nitric oxide production. The project seeks to elucidate one mechanism by which the mechanical activity of continuous passive motion promotes healing of inflamed synovial joints.